ACTG223--CLARITHROMYCIN COMBINATION DRUG REGIMEN FOR MAC TREATMENT

The purpose of this study is to compare the efficacy and safety of three clarithromycin containing combinations regimens for the treatment of MAC in patients with HIV.